Improvement and standardization of a bioinformatic software suite for multiplexed imaging

PROJECT SUMMARY
Sarcopenia, or age-related muscle atrophy, afflicts 15% of the elderly, severely diminishing quality of life and
increasing morbidity and mortality. Our overarching goal is to elucidate novel causal mechanisms of sarcopenia
and use this knowledge to improve aged muscle function. We propose to capitalize on our discovery that a
reduction in the prostaglandins PGE2 and PGD2 in aged muscle results from catabolism by 15-hydroxyprosta-
glandin dehydrogenase (15-PGDH), the prostaglandin degrading enzyme, the subject of the parent grant of this
application. As described in the grant, we made the unexpected finding that 15-PGDH expression is significantly
increased in aged mouse and human muscles. Additionally, our data show that overexpressing 15-PGDH in
young muscles induces an aging phenotype accompanied by a marked decrease in muscle mass and function,
mimicking sarcopenia. The central hypothesis of the parent grant is that during aging, senescent and inflamma-
tory cells accumulate in the muscle microenvironment and express 15-PGDH, which degrades PGE2 and PGD2,
and causes muscle wasting. Therefore, inhibition of 15-PGDH in aged muscles will increase PGE2 and PGD2
lipid metabolites and augment muscle mass and strength. Our aims are to (i) elucidate the roles of PGE2 and
PGD2 in skeletal muscle homeostasis, (ii) identify the cell source of 15-PGDH and prostaglandin dysregulation
in aged muscle, and (iii) restore aged muscle function and mass by inhibiting 15-PGDH. Parent grant Aim 2
employs a cutting-edge single cell multiplexed imaging technology called CODEX (CO-Detection by indEXing).
CODEX allows us to resolve up to 60 markers simultaneously in single tissue sections. This breakthrough meth-
odology will enable a determination of whether senescent cells comprise a cell source of 15-PGDH and allow us
to resolve the spatial relationships among the diverse cell types present in aged muscles. Each CODEX experi-
ment produces terabytes of high-resolution images that must be deconvolved and stitched together. We have
developed 3 software packages (CRISP, HFCluster, and SpaCE) to deconvolve, stitch, cluster, and annotate
our CODEX data and computationally identify signaling among cell types. Our goal for this supplement is to fund
a skilled and dedicated lab associate for the continued improvement and maintenance of this software, specifi-
cally to improve user interface, standardize data input formats, and provide compatibility for a range of multi-
plexed imaging workflows. These improvements will not only help us achieve the second aim of our grant, but
they will also make the software we develop far more user-friendly and readily accessible to the muscle biology
and aging communities, as well as to all users of CODEX and other multiplexed imaging modalities.

Public health relevance
NARRATIVE Sarcopenia impacts over 50% of people over age 80, however there are no approved pharmacological or cell therapies to treat sarcopenia and reduce muscle wasting; the best clinical interventions available are physical activity and good nutrition. Our parent grant uses novel spatial-omic approaches to study 15-PGDH as a thera- peutic target for sarcopenia. Here we propose to improve the usability and longevity of software we developed as part of this research program.